DEVELOPING A NATURALISTIC PARADIGM FOR EARLY DETECTION OF COGNITIVE IMPAIRMENT

PROJECT SUMMARY/ABSTRACT
Early detection of cognitive decline in older adults (OA) is a public health priority. The pathology of Alzheimer's
disease (AD) begins more than 20 years before memory loss develops, but dementia diagnoses often occur
late in the process of cognitive decline. AD is a progressive disease and early detection of cognitive decline
may slow disease progression by providing appropriate treatments earlier. There is growing evidence to
suggest the possibility that depression in OA is a risk factor for cognitive decline and AD, potentially acting
through perceived stress. However, it remains unknown whether depression in OA is a prodrome, a cause, or a
consequence of cognitive decline. Moreover, we often rely on cognitive assessments in the lab, and could
instead leverage real-world behaviors to detect early shifts in cognition. This study seeks to fill this knowledge
gap through three aims: (Aim 1) identification of cross-sectional and longitudinal relationships between
cognitive performance, perceived stress, and psychiatric symptoms in an existing sample from the Indiana
Alzheimer's Disease Research Center; (Aim 2) development of natural language processing algorithms to
detect and quantify risk factors for depression in midlife and OA; and (Aim 3) ecological momentary
assessment of the daily cognitive functioning, emotions, and stress in OA, using validated mobile cognitive
tasks. Completion of these aims will provide a test of the relationship between cognitive aging and depression
in OA using a multimodal approach. Dr. Rutter's overarching K01 career development goal is to develop a
naturalistic paradigm for early detection of cognitive decline. Aim 1 will define the theoretical framework for this
paradigm; Aims 2 and 3 then apply this framework to real-world stimuli to determine whether these provide
more sensitive measures of detecting cognitive decline. The integrated training and research plans proposed
here will provide Dr. Rutter with advanced training in several critical areas needed to position here as an expert
on aging. The mentorship and guidance from her team of national leaders will allow Dr. Rutter to achieve
targeted training in the following domains: (1) cognitive aging, AD, depression and wellbeing in OA, and
technology use in OA (Krendl & Holden), (2) natural language processing approaches to understanding risk
factors for depression in midlife and OA (Bollen), (3) implementation of ecological momentary assessment and
analysis of intensive longitudinal cognitive data in OA (Finn & Germine), and (4) career development skills in
grantsmanship, leadership, and research (Krendl, Holden, & Hawkins). These training objectives will be
achieved through a combination of coursework, conferences, workshops, directed readings, mentorship
meetings, and completion of the primary K01 study. Indiana University Bloomington provides an outstanding
environment for these training and research objectives. This K01 award will provide an essential bridge
between Dr. Rutter's prior training and research experience, and her career goal of becoming an independently
funded researcher who specializes in the interplay of depression and pathological cognitive aging.

Public health relevance
PROJECT NARRATIVE To accurately detect preclinical Alzheimer's disease, it is essential to develop early indicators of cognitive decline that can be obtained in real-world settings, and across multiple timepoints. Traditional clinical assessments of older adults are burdensome and may fail to capture momentary shifts in everyday mood or cognition that could identify potential mechanisms associated with cognitive decline. The proposed approach, a naturalistic paradigm to detect cognitive decline, utilizes assessment of older adults in their daily life, enhances ecological validity, and allows for individualized monitoring of subtle changes in three ways: (1) through examination of cross-sectional and longitudinal relationships between cognitive performance, perceived stress, and psychiatric symptoms in an existing sample from the Indiana Alzheimer's Disease Research Center; (2) through natural language processing algorithms designed to detect and quantify risk factors for depression in midlife and older adults; and (3) through an ecological momentary assessment of the daily cognitive functioning, emotions, and stress in older adults, using validated mobile cognitive tasks.